Contribution of sympathetic nerves to herpes stromal keratitis

PROJECT SUMMARY/ABSTRACT
Herpes simplex virus type 1 (HSV-1) corneal infections are leading infectious causes of blindness world-wide.
It is well established that the blinding form of HSV-1 infection called herpes stromal keratitis (HSK) is caused
by the immune response to the virus rather than by a direct effect of the virus on corneal cells. The disease
tends to recur in people because the virus invades and establishes a quiescent (latent) infection in sensory
nerves during initial (primary) infection. HSV-1 periodically reactivates from the latent state, travels back down
the nerves to the cornea, and triggers recurrent bouts of HSK. A hallmark of HSK is loss of corneal sensitivity
that has been associated with loss of corneal sensory nerve endings. However, the role of the neuroimmune
axis in pathology is incompletely understood. Our preliminary studies in mice demonstrated that a host factor,
Sterile alpha and TIR motif containing 1 (SARM1), acts to prevent HSK as SARM1 deficient mice develop
more severe HSK compared to WT controls. While SARM1 is conventionally linked to neuronal cells, it also
can function in various immune cell populations. Therefore, we plan to assess the functional consequences of
SARM1 during HSK in nerve and immune cells. Specifically, our first aim will investigate how SARM1
deficiency may affect viral control and the generation of the anti-viral immune response over time. Our second
aim will focus on defining immune cell intrinsic mechanisms of SARM1 by comparing immune cell functionality,
migration, and metabolism of SARM1 deficient immune cells to WT immune cells in vivo and in vitro. Finally,
our third aim will investigate how SARM1 deficiency affects sensory and sympathetic nerve growth during
steady state and in the context of neurotrophic viral infection. We posit a role that SARM1 limits the activation
of inflammatory monocytes while also limiting the outgrowth of sympathetic nerves, which we have found to
contribute to pathogenesis in ocular HSV-1 infection. Overall, we anticipate that our studies will identify SARM1
as a host factor that plays an integral role in preventing HSK.

Public health relevance
PROJECT NARRATIVE Herpes simplex virus type 1 induced corneal stromal keratitis (HSK) is a leading infectious cause of blindness. This proposal has the potential to define, for the first time, an important contribution of the factor, Sterile alpha and TIR motif containing 1 (SARM1), and in so doing so identify a new target(s) for therapy.